PHARMACOKINETICS OF INTRAVENOUS RECOMBINANT G-CSF IN NEWBORN INFANTS

The purpose of this research is to measure levels of G-CSF in infants blood and urine several times on the first and fifth day that the infant receives G-CSF.